Spatiotemporal Health Analytics: Geospatial connections to toxicology

Within environmental health sciences, there is an ever-growing need for methodological development and applications of spatiotemporal models that can handle the large, complex data and interdisciplinary challenges. Towards this end, the central theme of the Spatiotemporal Health Analytics Group (SHAG) is to develop spatiotemporal methods and applications in environmental and human health exposure science while also exploring innovative applications of geospatial and spatiotemporal methods in toxicology.